Clinician perspectives on the postpartum pain experience and attitudes about pain management

PROJECT SUMMARY
Opioid misuse has been declared a national emergency in the United States. More than half of hospitalized
patients receive an opioid during their hospitalization. As birth is the most common reason for hospitalization,
reproductive-aged individuals are particularly vulnerable to opioid exposure and are an important population for
addressing the opioid epidemic. Indeed, our data have demonstrated the high frequency of postpartum inpatient
and outpatient opioid use, the wide variation in postpartum pain management, the lack of alignment of opioid
prescribing with patient reports of pain, and the contributions of obstetric clinicians to opioid prescribing.
The opioid epidemic has a differential impact by race/ethnicity; individuals of minority race/ethnicity are less likely
to receive an opioid for pain management than non-Hispanic White individuals. Notably, our data show that,
despite reporting higher levels of pain postpartum, minority race/ethnicity birthing individuals receive less opioid
treatment as inpatients and are less frequently prescribed an opioid upon hospital discharge. A complete
understanding and, ultimately improvement, of these experiences and reduction in disparities requires a deeper
delve into influences which guide clinicians in their management of postpartum pain.
This proposal aims to fill an unmet need for a systematic, in-depth, and unbiased evaluation of obstetric
clinicians’ experience of postpartum pain management. We propose a prospective qualitative study of
obstetric clinicians, examining factors which influence their approach to postpartum pain management, biases
which may contribute to disparities, and their perspectives and preferences of interventions to reduce opioids
and improve pain control. We will conduct in-depth focus groups of up to 50 obstetric clinicians, including
physicians, advanced practitioners, and nurses. Aim 1 will evaluate beliefs and factors which influence
clinicians’ management of postpartum pain, including potential clinician-level biases which may contribute to
disparities. Using the Consolidated Framework for Implementation Science, Aim 2 will evaluate clinicians’
perspectives and preferences of interventions to reducing postpartum opioid prescribing and improving
pain control, in order to optimize the implementation of future interventions.
Optimizing postpartum health, reducing opioid overuse, and reducing disparities in care and outcomes are critical
goals of major professional societies and the NICHD 2020 strategic plan. In combination with patient-focused
research on postpartum pain management (3R01HD098178-02S1), this work aims to create an essential
foundation from which to develop and implement effective and equitable interventions to optimize postpartum
opioid prescribing and pain management.

Public health relevance
PROJECT NARRATIVE The postpartum period is a high-risk period for opioid exposure and subsequent persistent use, yet concerns about excessive opioid exposure must also be considered alongside the documented inequities in pain management that exist for minority individuals. Our work has demonstrated that healthcare clinicians offer a wide range of approaches to postpartum pain management and that opioid prescribing is not fully aligned with patient reports of pain. To address gaps in understanding regarding clinician factors which influence variations pain management and disparities therein, we propose a qualitative investigation of obstetric clinician to evaluate factors which influence their approach to postpartum pain management, biases which may contribute to disparities, and their perspectives on and preferences of interventions to reduce opioids and improve pain control in order to optimize the implementation of future interventions.